Digital Health Technologies for Monitoring Motor Function in Progressive Supranuclear Palsy and Dementia with Lewy Bodies

PROJECT SUMMARY
Progressive supranuclear palsy (PSP) is a severe and rapidly progressive Frontotemporal Lobar Degeneration
(FTLD) syndrome that lacks effective treatment and leads to a rapid onset of dementia, disability, and death.
Dementia with Lewy Bodies (DLB) is the second most common type of neurodegenerative dementia after
Alzheimer’s disease. Both PSP and DLB cause significant motor impairment, resulting in progressive loss of
independence in activities of daily living, such as eating, dressing, and writing. There are no FDA-approved
treatments for FTLD syndromes (including PSP) or DLB. One of the key challenges in the development of new
effective therapies for DLB syndromes is the lack of validated instruments and biomarkers to measure disease
severity, disease progression, and the effect of therapeutic interventions.
Since 2019, BioSensics, Massachusetts General Hospital (MGH) and Johns Hopkins University (JHU) have
partnered to develop a wearable-based remote monitoring solution for FTLD syndromes. The solution uses
PAMSysTM, a patented and validated pendant sensor for monitoring physical activity, posture, and walking
parameters during activities of daily living. Through a Direct Phase II SBIR award (R44AG080861) from the
National Institute on Aging, we have demonstrated the feasibility of using PAMSys for tracking ambulatory
change in PSP. In this project, we will extend our work by using both PAMSys and PAMSys ULMTM wrist sensors
to enable comprehensive monitoring of upper and lower limb function. PAMSys ULM is a patented wrist sensor
solution for monitoring goal-directed movements of the upper limb during activities of daily living. The primary
goal of the project is to qualify digital monitoring biomarkers of motor function for both PSP and DLB
with the FDA Biomarker Qualification Program (BQP). Context of Use: COU1 and COU2) Monitoring
by working
biomarkers to track ambulatory change over time in PSP and DLB, COU3 and COU4) Monitoring biomarkers to
track changes in upper limb function over time in PSP and DLB. We will work with CurePSP, The Association
for Frontotemporal Dementia, and the Lewy Body Dementia Association to recruit study participants and
leverage an NIH-funded platform trial in PSP to facilitate patient recruitment and assure enrollment diversity.
We will demonstrate the accuracy (analytical validation) of both PAMSys and PAMSys ULM in PSP and DLB.
In addition, we will conduct a proof-of-concept study to demonstrate the feasibility and reliability of monitoring
motor function in PSP and DLB using PAMSys and PAMSys ULM. Afterward, we will conduct a multisite
longitudinal clinical validation of digital health technologies for monitoring motor function in a sizeable and
diverse cohort of PSP and DLB patients and compare this to functional scales and patient-reported outcome
measures. Moreover, as recommended by the FDA BQP, we will conduct interviews with all participants using
the Technology Acceptance Model to examine the perception of benefit, technology acceptance and anxiety,
and attitude toward use from patients’ point of view.

Public health relevance
PROJECT NARRATIVE Progressive supranuclear palsy (PSP) and Dementia with Lewy Bodies (DLB) cause significant motor impairment, which is currently assessed through expert examination at clinical visits. Such in-clinic assessments are time-consuming, subjective and of limited sensitivity, creating key challenges for clinical trials and affecting the development of new effective therapies for PSP and DLB. In this project, we will conduct analytical and clinical validation of wearable-based digital health technologies for monitoring upper and lower limb function in PSP and DLB that enable frequent, at-home monitoring of motor function, and could be incorporated into future clinical trials.